Improving detection and interpretation of clinically relevant structural variation

Project summary and abstract Human disease is caused by several different types of structural variation, including deletions, duplications, and inter and intra chromosomal rearrangements. Currently, no one diagnostic test can identify all of these changes, which can lead to a diagnostic odyssey with serial genetic testing. Whole genome sequencing (WGS) allows for the detection of point mutations, small indels and large structural variants (SV) in a single test, and has the potential to replace both exome sequencing and chromosomal microarrays in the clinical setting. However, the adoption of clinical testing for SVs from WGS has been hampered by both technical and interpretative challenges. Existing algorithms for the detection of SVs from WGS suffer from high false-positive rates, reference bias, and mappability issues. This proposal will address the issues of detection, interpretation, and reanalysis of copy number and other structural variation in individuals presenting with pediatric genetic disorders. We will utilize SV data from various types of genomic technologies in order to minimize false positives, incorporate genomic positional information, and enhance pathogenicity determination by the prioritization of these variants. In this proposal, we will utilize two orthogonal methodologies, chromosomal microarray and de novo assembled optical genome maps, to optimize the sensitivity and specificity of SV detection. Since the number of SVs identified from whole genome data can number into the thousands, the lack of tools for annotation and interpretation of SVs results in a huge burden for clinical laboratories. We propose to facilitate the prioritization of clinically-relevant SV by developing web-based analysis tools that integrate patients’ phenotypes with SV-specific annotations for efficient prioritization and reporting of clinically relevant SVs. We will apply these tools towards the reanalysis copy number variants of uncertain clinical significance previously identified in our clinical laboratory. In addition, additional characterization of duplications of uncertain clinical significance with be investigated using targeted optical maps to determine the location and orientation of the duplicated region. The impact of new gene discovery on SV interpretation, as well as additional information regarding insertional locations, will be assessed for their contribution to changes in classification of SVs.

Public health relevance
Project narrative This proposal will address the issues of detection, interpretation, and reanalysis of copy number and other structural variation in individuals presenting with pediatric genetic disorders. We will utilize data from various types of genomic data (chromosomal array, exome and genome sequencing, and optical genome data) in order to minimize false positives, incorporate genomic positional information, and enhance pathogenicity determination by prioritization of these variants.